Cochlear Implant Clinical Research Symposia (Three Years) Covering the Years 2024 through 2026

Project Summary/Abstract
This application seeks partial funding for three years of cochlear implant (CI) clinical research
conferences to be convened by the American Cochlear Implant Alliance in July 2024 (Vancouver,
Canada), April 2025 (Boston) and May 2026 (Washington, DC). The CI meetings provide a unique
opportunity for CI clinicians from across the continuum of care (i.e., ENTs, audiologists, speech
pathologists, psychologists), educators, and scientists to learn together. With the rapid rate of change in
the field and concerns on how to manage the growing number of new recipients with expanded
indications, alongside of an installed base of patients who must be cared for over their lifetime,
conference interests have expanded to include research to practice topics on serving this population in a
challenging and changing healthcare environment.
Attendees will have the opportunity to explore current and emerging topics that significantly impact CI
outcomes and delivery mechanisms for patients across the lifespan. Podium presentations, panel
discussions, featured talks, and posters will highlight clinical research on: team approach to patient
management including expanded indications of special needs populations; cognitive impacts of CI in
older adults; managing bilingual patients and families; innovative models of service delivery for CI
programs (including telehealth); roles of therapy, education, and family engagement in the CI process
for adults and children; advances in CI technology and surgical techniques; hearing preservation; CI
in single sided deafness, role of vestibular assessment in the CI process; and gene therapy, genetics,
and alternative methods of managing hearing loss. The impact of the whole team in the CI process
will be examined. This aim is unique to this conference and will provide an in-depth critical
assessment of the various factors that impact on outcomes for patients across the lifespan. As adults
of all ages have become a larger proportion of the cochlear implant population, our focus will address
the diversity and needs of the adult population, alongside of children.
Students may apply for waived registration and financial support and may enter a student poster
competition with interviews conducted by an interdisciplinary committee. An afternoon symposium for
(re)habilitation professionals and others on CI teams providing clinical or educational services to children
and their families will be offered. Among the pediatric topics to be explored are listening and literacy and
provision of CI in single sided deafness. Adult rehabilitation post CI will address adults’ specific needs.
Research and clinical practice will be explored for both populations.

Public health relevance
Project Narrative With the expansion of cochlear implant candidacy, the pool of people who are likely to qualify now includes children and adults with more residual hearing including those with single sided deafness or asymmetric hearing loss. Expected CI outcomes are characterized by a fuller hearing experience that includes spatial hearing, listening in noise, access to environmental sounds, and enjoyment of music as well as associated benefits like cognition in older adults and quality of life in recipients of all ages. The CI conferences will explore these topics, addressing how CI professionals can best provide appropriate clinical services and reach underserved groups while still maintaining a sustainable clinical practice.